Deriving a de novo adolescent addiction treatment from developmental brain data

PROJECT SUMMARY
This administrative supplement within Dr. Feldstein Ewing’s Mid-Career Investigator Award (K24) aims to
support PI Feldstein Ewing’s development of innovative, translational (clinical + imaging) research in
adolescent alcohol treatment. The K24 protects time to facilitate her mentorship of emerging underrepresented
investigators. Her career development and mentorship aims are tightly and synergistically linked to advance
planned research aims. Dr. Feldstein Ewing’s 5-10 year research plan is to develop more efficacious treatment
for adolescents who struggle with hazardous use. Dr. Feldstein Ewing believes that advances from this area
are most likely to stem from integrative approaches that directly query the developing brain, and aims to tailor
articulated interventions that are responsive to that very specific period of neural development. Translational
research in adolescent addiction is very labor intensive. K24 research funding provides Dr. Feldstein Ewing
with protected time from the call of administrative duties, which are often highly time intensive, but
unfortunately do not advance research or mentorship. Thus, protected time available within this mechanism
facilitates precisely the type of protected coverage requisite for freeing up the investigator to learn more
advanced quantitative methods that are being used to maximize existing data that Dr. Feldstein Ewing already
has, to propel the field forward in terms of developing novel interventions for high-need adolescents struggling
with hazardous use. This protection also facilitates protected time for Dr. Feldstein Ewing to engage and
involve underrepresented mentees at every stage of this process. As with many other academic centers,
without this K24, this type of protected research/mentorship time would not otherwise be available to Dr.
Feldstein Ewing. This coverage is crucial for advancing innovations in adolescent treatment, at a critical
juncture where the resources and opportunity are available for this work to be done. This is a high area of
interest and need for NIAAA; this K24 will launch a new field of scientists in this domain of adolescent
alcohol and addiction research, and its intervention.

Public health relevance
PROJECT NARRATIVE Dr. Feldstein Ewing has a strong track record of grantsmanship within NIAAA. This administrative supplement within Dr. Feldstein Ewing’s Mid-Career Investigator Award (K24) would offer requisite protected time to support underrepresented trainees’ exploration into under-investigated aspects of adolescent treatment response in the field of hazardous alcohol use, along with needed protected coverage to mentor this important next generation of patient-oriented treatment researchers.